Frailty and Monitored Anesthesia Care for Cataract Surgery in Older Adults

Project Summary
The vast majority of older adults undergo cataract surgery with 1-to-1 intraoperative monitoring and sedation
administered by an anesthesiologist or nurse anesthetist (a.k.a., “monitored anesthesia care” or “MAC”).
Proponents of MAC believe that cataract patients—many of whom are frail due to a combination of advanced
age, multimorbidity and underlying visual impairment—generally benefit from close intraoperative monitoring
by an anesthesia professional. However, given the procedure’s overall safety profile and the projected increase
in cataract surgery demand as the US population ages, policymakers, clinicians, and payers have questioned
whether the routine use of MAC for cataract surgery should continue in the US. Currently, there is inadequate
evidence to predict which patients would be at highest risk for harm if MAC were to be removed as a
component of routine cataract surgery. The rationale underlying the proposed research is that identifying the
characteristics of patients at highest risk of harm could help facilitate a careful transition to non-MAC cataract
surgery for the majority of patients who would be safe to proceed (and would not be harmed) without MAC.
The central hypothesis is that the provision of MAC is only necessary for a relatively small subset of high-risk
older adults undergoing cataract surgery. To test this hypothesis, the proposed research plan will investigate
three aims. Aim 1 will examine the relationship between frailty, MAC, and the incidence of adverse events after
cataract surgery through retrospective analysis of Medicare claims. Aim 2 will shed light on the facilitators and
barriers for performing cataract surgery without MAC using semi-structured interviews of ophthalmologists
whose practices represent a range of MAC utilization. Aim 3 will carry out a pilot study of low-risk older adults
undergoing cataract surgery to determine feasibility and acceptability of non-MAC sedation for cataract
surgery. These aims will create foundational knowledge to support future studies that can determine whether
MAC can safely be removed as a component of routine cataract surgery in low-risk older adults. The
Candidate is an anesthesiologist and health services researcher at UCSF. The Candidate, her mentors and
her scientific advisors have developed a comprehensive career development plan that aligns well with the
Aims of the proposed research. The key elements of this plan include training and didactics to obtain specialty
knowledge in the following areas: 1) Principles of geriatrics and gerontology, 2) Biostatistical methods for
advanced causal inference; 3) Introduction to qualitative research methodologies; 4) Implementation science
and feasibility pilot studies, and 5) Structured career development with exposure to thought leaders in
geriatrics, health services research, ophthalmology, and anesthesiology. This career development award will
help the Candidate achieve her goal of becoming a national leader in geriatric perioperative health services
research at the forefront of promoting evidence-based, high-value surgical and anesthetic care in older adults.
With strong institutional commitment, the Candidate is well-positioned to attain research independence.

Public health relevance
Project Narrative Due to the significant advances in modern cataract surgical technique over the last 30 years, the risk of cataract surgery is now considered low enough that some have questioned the need for anesthesiologists and nurse anesthetists in the operating room to provide continuous intraoperative monitoring and intravenous sedation (a.k.a., “monitored anesthesia care” or “MAC”). However, we do not know which patients would be harmed if anesthesia professionals were removed as a component of routine cataract surgery. This study will help identify high-risk patients who would still benefit from monitored anesthesia care during cataract surgery while creating new knowledge about how best to implement potential changes in the type of sedation offered to patients who are undergoing this procedure.